Stress and Anxiety Effects on Overactive Bladder: A Controlled Study

PROJECT SUMMARY
Overactive bladder (OAB) (i.e. urinary urgency, with or without urgency urinary incontinence, frequency, and
nocturia) affects 1 in 7 U.S. men and women and results in substantial impairment to quality of life (QOL). To
help self-manage and cope with OAB, many people adopt compensatory bladder behaviors, such as restricting
fluids, using containment products, strategic planning and mapping restroom access, and even curtailing
activities or travel altogether, which further adversely impact QOL. These behaviors may be driven by anxiety
and stress related to urinary urgency and incontinence episodes as well as ensuing distress and embarrassment.
Prior research has linked anxiety and OAB: up to 40% of women and 30% of men with OAB also have
generalized anxiety disorder. The link between stress and OAB is less studied. In animals, experimental stress
can cause OAB-like symptoms and behaviors as well as bladder and somatic hypersensitivity. In limited human
studies, women with OAB may have greater physiologic and psychologic stress reactivity, and acute stress may
exacerbate urinary urgency. However, how stress impacts on the bladder in the context of OAB or what
psychological factors drive compensatory behaviors that impair QOL in OAB remain unknown, as there are no
highly-controlled studies of anxiety-OAB links. Understanding these relationships would be a critical advance to
individualizing care of patients with OAB. The proposed project will comprehensively investigate for the first time
how stress, anxiety and OAB interact, including the impacts on bladder sensitivity, urinary symptoms, and
compensatory bladder behaviors. We propose a feedforward loop, whereby increased OAB symptoms increase
anxiety (via response to coping with stressful situations), which in turn increases OAB symptoms (via increased
bladder sensitivity). We further propose that compensatory behaviors are driven by anxiety-related learning
processes that help perpetuate this relationship. We will test our hypotheses in a sample of men and women
with OAB and healthy controls. Aim 1 will test the hypothesis that acute, experimentally induced psychological
stress will be more strongly associated with increased bladder sensitivity in OAB patients than in controls, using
a novel bladder sensation meter with oral hydration and stress induction procedures. Aim will test the hypothesis
that psychological stress and anxiety will have concurrent and lagged effects on day-to-day urinary symptoms
that are stronger in individuals with OAB than in controls, using an ecological momentary assessment approach
(7-day electronic diary) to examine prospective associations between everyday perceived stress, anxiety and
urinary symptoms. Aim 3 will test the hypothesis that compensatory behaviors (i.e. coping) used at the time of
voiding will be associated with subsequent reductions in anxiety levels, using a 3-day sensation-related bladder
diary that captures concurrent bladder behaviors and anxiety symptoms as well as lagged symptoms 30 minutes
post-void. Delineating these relationships and patterns will allow for identification of potentially modifiable factors
or areas for intervention, which we envision as a future R01 clinical trial submission.

Public health relevance
PROJECT NARRATIVE Understanding how underlying disease mechanisms in overactive bladder contribute to the development of urinary symptoms, including urinary urgency and urgency incontinence, is highly relevant to public health. The proposed, interdisciplinary research that includes experts in Urology, Psychology, and chronic pain research will contribute to the fundamental knowledge of how psychology relates to bladder sensitivity and to psychological burdens in people with overactive bladder and how this can be measured effectively. This will allow future studies in which interventions to improve bladder health and incontinence can be implemented and outcomes recorded, with the goal of improving bladder health.